Pilot and Feasibility Program

The Pilot and Feasibility grant program of the Yale DRC is managed through the Pilot and Feasibility Core. The
functions of the Core are to solicit applications from investigators in the Yale School of Medicine and throughout
Yale University, to carry out peer review of the applications, and to select meritorious projects for support. Grants
are awarded for up to 2 years depending on progress that is made in the first year of funding and plans for the
2nd year. The Core is directed by Kevan Herold, MD who works with an oversight committee that makes final
funding selections of grants for support. In the past funding cycle, the Program benefited from additional support
available through the CTSA/ARRA funds as well as collaborative support of translational studies with the Yale
Clinical Translational Science Award (CTSA). Since the inception of the Yale DRC in 1993, interest and
applications to the program has increased – in the past funding cycle, 88 applications were received and 28 were
supported. While the majority of applications are received from established investigators, there is a bias towards
funding new investigators, many of whom have used the P+F award to obtain preliminary data to apply for
external grant support. From the past funding cycle, 11 new external grants were obtained generating over $7M
in new research revenue. Studies supported by the P+F program have resulted in more than 40 peer-reviewed
publications during the last two funding cycles. The P+F program has also been a mechanism for initiation of
new collaborations often between basic and translational scientists. Examples of these collaborations include
studies of innate immune pathways that are associated with hepatic insulin resistance and cellular mechanisms
of glucose metabolism in adipocytes. In summary, the P+F core plays a vital role in attracting new investigators
to the diabetes field and recruiting established investigators who are new to diabetes or are developing a new
area of diabetes-related research. By effectively utilizing additional sources of revenue, the Core has been able
to maintain a high level of funding which has resulted in a high level of productivity.